Structural and mechanistic study of bat NLRP6 inflammasome in detecting RNA viruses

Abstract
Bats harbor the unique ability to host a wide array of emerging viruses, such as Ebola virus,
Nipah virus, Hendra virus, and severe acute respiratory syndrome coronavirus (SARS-CoV).
These RNA viruses are highly pathogenic and often lethal to humans and animals. Intriguingly,
bats develop no/minimal signs of diseases in both natural and experimental infections. Significant
progress has been made to suggest the altered immunological networks and dampened
inflammatory signaling in bats. However, the direct viral sensing mechanisms in bats and the
unique immunological features that distinguish bats from other mammals remain poorly studied.
Inflammasomes are multi-protein signaling platforms that form in epithelial cells and myeloid
cells upon stimulation by pathogen and damage signals. Their primary function is to active the
inflammatory caspases such as caspase-1. Canonical inflammasome sensors consist mainly of
nucleotide-binding domain (NBD), leucine-rich repeat (LRR)-containing (NLR) family proteins.
Among these NLR proteins, NLRP6 is a unique pattern recognition receptor that is predominantly
expressed in intestinal and liver system. The inflammasome function of NLRP6 has been reported
to directly detect the RNA viruses (rotavirus and mouse hepatitis virus) that infect the
gastrointestinal (GI) tract. On the other hand, the excessive activation of NLRP6 inflammasome
may exacerbate the tissue damage and cause the autoinflammatory diseases. In bats, the GI
tract represents one major organ for viral infection, while infections rarely cause symptoms. The
long-term goal of our project is to understand the specific inflammasome sensing mechanisms in
detecting RNA viruses in the intestinal epithelium of bats and gain the insights of how bats protect
themselves from the pathogenesis of inflammation-induced intestinal barrier dysfunction.
In this application, we propose to pursue the following specific aims: 1) Determine the cryo-
EM structures of bat NLRP6 monomer, elucidate the biochemical foundation of bat NLRP6-
dsRNA interaction, determine the cryo-EM structures of bat NLRP6 with viral dsRNA and compare
the structural mechanisms of dsRNA sensing and inflammasome signaling among bat, mouse
and human NLRP6; 2) Elucidate the RNA virus-induced bat NLRP6 inflammasome signaling in
reconstituted intestinal epithelial cells (IECs), analyze the bat inflammasome signaling in
Eonycteris spelaea (Es) in response to bat-borne RNA viruses, study the genetic role of bat
NLRP6 in regulating inflammasome signaling in bat primary IECs/bat intestinal organoids. The
proposed studies will guide the development of therapeutics to target GI inflammatory disorders
in human based on the molecular details of bat NLRP6 inflammasome.

Public health relevance
Narrative Bat inflammasomes play critical roles in tolerating the infection of high-profile viruses and preventing the autoinflammatory syndromes resulting from excessive signaling. This project will investigate the structural and functional mechanisms of bat NLRP6 inflammasome in detecting RNA viral infection. Completion of this work will produce important insights into the development of novel therapeutics to target NLRP6-related inflammatory disease in human by learning from the unique molecular features of bat NLRP6 inflammasome.